Systematic Testing of the VTA-BBB Hypothesis

PROJECT SUMMARY
Survival depends on forebrain computations that optimize behaviors to meet body needs. Vascular signals from
the body, transmitted through the blood-brain barrier (BBB), are an essential pathway for conveying this
information. However, the BBB stringently limits molecular traffic into the brain. This protection is essential to
adaptive cognitive function, and failure of the BBB is a hallmark of many diseases, including vascular dementia
and deterioration associated with Alzheimer’s Disease and depression. Here, I test the hypothesis that the
brain resolves tension between the need to access critical information about body state and the need to
keep the brain safe by dynamically regulating BBB permeability, increasing it only at key behavioral
moments. Specifically, I predict that increased activity of Ventral Tegmental Area (VTA) neurons
increases BBB permeability. As a second, independent motivation for increased brain access during periods
of high behavioral relevance, computation at these times may require greater resources from the body. In support
of this VTA-BBB Hypothesis, VTA neurons increase activity in response to a wide variety of behaviorally-relevant
events. Further, VTA axons are well-positioned, as they are often in close apposition to forebrain vessels, and
they release multiple neurotransmitters that drive key components of the neurovascular unit.
Aim I of this proposal outlines the work I have accomplished using in vivo multiphoton calcium and vascular
imaging, and full-field optogenetic stimulation. My Preliminary Data from these experiments support the
hypothesis that VTA axon activity, endogenous and evoked, predicts increased BBB permeability in
mouse primary somatosensory cortex (SI). Aim II provides details of experiments I will perform to complete
this work, by testing the prediction, supported by my Preliminary Data, that VTA axons proximal to vessels
(<10µm) drive faster and larger increases in BBB permeability than more distant axons. I will also test the related
prediction that reward-predictive cues and reward events, known to activate neocortically-projecting VTA
neurons, also drive increased BBB permeability. To test the first prediction, I will employ holographic optogenetic
stimulation to drive specific subsets of VTA axons, grouped by their location relative to vessels. To test the
second prediction, I will image mice trained to associate high amplitude vibrissal deflections with reward. This
work will provide valuable new training in optical and behavioral techniques. I will further advance these skills,
and my analytical abilities, by attending workshops and courses, and by one-on-one training and collaboration.
Aim III describes the training I will obtain as a postdoctoral student, focused on more sophisticated, state-specific
behavioral paradigms, and on learning molecular techniques to assay high-dimensional signals that indicate
body states. Whether or not my data ultimately support the hypotheses described, the training provided in these
Aims will ideally position me to build my future lab, focused on discovering new pathways through which body
systems interact with the brain to create behavior.

Public health relevance
PROJECT NARRATIVE Adaptive behaviors, such as goal-directed actions and learning signaled by ventral tegmental area (VTA) neurons, require the integration of body signals gated by the blood-brain barrier (BBB). Dynamic changes in BBB permeability are not well understood and disorders of motivated behavior and learning, such as depression and Alzheimer’s Disease, clinically manifest with vascular dementia and deterioration associated with pathological changes in BBB permeability. To discover new pathways through which body systems interact with the brain and affect behavior, I will use foundational techniques learned from my dissertation and postdoctoral work in my future lab; in vivo multiphoton calcium and vascular imaging, holographic optogenetic stimulation, nuanced behavioral training, and molecular techniques to measure blood signals.